RESEARCH ON DRIVING RISK AMONG NOVICE TEENAGE DRIVERS

The investigator will conduct research on supervised practice driving among newly licensed teens and will examine its effects on the driving performance of such teens.